Evalulation of Echinacea in a Human Rhinovirus Challenge

DESCRIPTION (APPLICANT'S ABSTRACT): Echinacea is a widely used herbal remedy for the common cold. Previous clinical trials designed to assess the efficacy of Echinacea for prevention or treatment of the common cold have produced inconsistent results. A variety of different Echinacea products have been used in these clinical trials. Recent studies indicate that different Echinacea preparations have dramatically different phytochemical profiles. The available clinical trial data provide no information about the potential role of the different constituents of Echinacea in common cold prevention or treatment. Our hypothesis is that the variation in reported clinical effectiveness may be due to differences in the phytochemical profile of the Echinacea preparations used. The experimental rhinovirus colds model is a well-established model for the study of the pathogenesis and treatment of the common cold. The combination of this model with detailed chemical analysis of Echinacea preparations will be used to address the inconsistencies in previous clinical trials. The purpose of this study is to use the experimental common cold model and preparations of Echinacea from a single species and plant part to systematically evaluate the effect of the different Echinacea constituents on rhinovirus infection and rhinovirus induced illness. This study will address the following specific aims: 1) Evaluate the effectiveness of chemically defined extracts of E. angustifolia root which contain alkamides, echinacoside or polysaccharidelglycoprotein for common cold prevention or treatment; 2) Assess the correlation between specific Echinacea metabolites in serum and nasal secretions and efficacy for prevention and treatment of colds; and 3) Determine the effect of different Echinacea preparations on the host response to rhinovirus infection.